Multifunctional Nanotechnology Platform for Triple Negative Breast Cancer Treatment

Project Summary: Triple-negative breast cancer (TNBC) accounts for approximately 15% of invasive breast
cancers and is associated with aggressive tumor biology, poor prognosis, resistance, visceral metastases and
earlier disease recurrence. TNBC is more common in younger women than in older women and in African-
American and Hispanic women. Platinum-based drugs showed higher sensitivity in TNBC compared to non-
TNBC patients and recently there has been a renewed interest for platinum therapy in TNBC, especially
combination of carboplatin with paclitaxel (PTX). Sacituzumab govitecan is made up of an anti–Trop-2 antibody
linked to the chemotherapy drug (SN-38) and was cleared by the FDA for TNBC patients who have
undergone at least two prior chemotherapies. The FDA granted an accelerated approval for the
immunotherapy drug atezolizumab in combination with chemotherapy (nab-paclitaxel) for the treatment of
TNBC (for tumors positive for PD-L1). Thus chemotherapy is important in the therapeutic management of
TNBC even in the advent of immunotherapy and targeted therapy. However, chemotherapies are known
to cause fatal peripheral neuropathy in addition to poor response, metastasis, relapse and development of
multidrug resistance. The goal of this application is the development of multifunctional targeted nanoparticles
capable of achieving better outcomes for TNBC patients: (a) targeted delivery of large doses of multiple drugs
into cancer cells (per a single biorecognition event compared to a single immunotargeted drug (e.g.
sacituzumab govitecan-hziy)) to maximize therapeutic effects while reducing systemic toxicity (off target
toxicity); (b) EGFR-receptor targeted nanoparticles that promote intracellular drug delivery and release and
which can bypass multidrug resistant protein (p-glycoprotein) which mediates efflux of drug molecules; (c)
capable of long circulation without being sequestered into the liver. EGFR is overexpressed by TNBC and
literature is replete with examples of the use of cetuximab in therapy by targeting EFGR. We hypothesize that
the development of biodegradable polymeric nanotechnology platform containing carboplatin and paclitaxel
in the core and using cetuximab (tagged on nanoparticle surface) as a targeting moiety will improve TNBC
patients’ outcomes, unlike repeated chemotherapy cycles with high doses of cytotoxic drugs. We hypothesize
that the dual-loaded multifunctional targeted nanoparticles will be active in vitro and show in vivo efficacy in
mouse xenograft models of TNBC positive tumors. Aim #1: Fabrication of polymeric dye-loaded and-paclitaxel
and carboplatin-loaded stealth hydrolysable crosslinked cetuximab surface-targeted polylactide (PLL)
nanoparticles. Aim #2: Characterization of anti-EGFR mAb (cetuximab) surface-targeted-PLL-nanoparticles
containing carboplatin and paclitaxel in the core. Aim #3: Biodistribution and efficacy studies in tumor-bearing
mice. This work will bring to bear the combined power of chemotherapeutic agents, molecular targeted therapy
and nanotechnology to overcome EGFR positive TNBC resistance and improve efficacy with minimal toxicity.

Public health relevance
Project Narrative: Triple-negative breast cancer (TNBC) accounts for approximately 15% of invasive breast cancers; it is associated with aggressive tumor biology, poor prognosis, resistance, visceral metastases and earlier disease recurrence and is more common in younger women than in older women and in African-American and Hispanic women. To overcome the issues of toxicity, resistance and poor efficacy, we plan to develop multifunctional targeted polymeric nanoparticles which will prove more effective with less toxicity than the current standard of care therapies. A combination regimen using carboplatin and paclitaxel in the core of the nanoparticles and highly selective anti-EGFR targeted agent (cetuximab) tagged on the surface of the nanoparticles coupled with the power of nanotechnology will obviate suffering from toxicity, improve efficacy and overcome resistance.